PREVENTIVE SERVICE REMINDERS: PATIENTS'PERSPECTIVES

This project emphasizes three current themes in the delivery of primary health care services: 1) the integration into clinical practice of the recommendations of the U.S. Preventive Services Task Force, 2) the increasing utilization of computer-based medical records with reminder systems for preventive services, and 3) the recognition of the importance of patients' perspectives in the delivery of health care services. Although studies have shown that computer generated physician reminders improve patient adherence with preventive services, patient reminders are less effective. The two aims of this project are to use qualitative methods to examine patient perceptions and attitudes about computer-generated reminder letters for preventive services and to use this information to design a more effective patient reminder. The sample will include patients from clinical practice of the Department of Family Medicine (DFM) at the Medical University of South Carolina and members of the larger Charleston community. The DFM has a fully computerized medical record system which provides preventive services reminders for physicians and patients based on the recommendations of the U.S. Preventive Services Task Force. Other residents of the local community will participate in the study to enhance the generalizability of the study. The project will be conducted in three phases over a one year period. An extensive series of focus groups, a qualitative research method, will be used. In the first phase of the project, the investigators will conduct twelve focus groups. These focus groups will permit the researchers to assess participants perceptions and attitudes about the Department's existing preventive service reminder letter and alternative forms of written communication. In the second phase, information from Phase One will be used by the project staff to revise the patient reminder system. In the third phase, six additional focus groups will be used to evaluate the redesigned reminder system. After completion of this project, the investigators plan to seek additional support to evaluate the redesigned patient reminder system in a randomized clinical trial.